Using Behavioral Economic Strategies to Address Obesity in Economically Disadvantaged Adults

Obesity is a public health crisis among adults from economically disadvantaged backgrounds, with over 85%
experiencing overweight or obesity and associated health ailments. To date, lifestyle interventions targeting
this high-risk group have produced modest weight losses. Thus, effective interventions for this vulnerable
population are urgently needed. New evidence from behavioral economics suggests that targeting lack of
reinforcement and bias for the present may improve treatment outcomes in adults from disadvantaged
backgrounds. Specifically, impoverished environments have been shown to have few sources of healthy
reinforcement, which makes responding to basic sources of reinforcement (e.g., palatable food) more resistant
to change. Moreover, all humans have been shown to have bias for the present, or a preference for immediate
rewards (palatable food) over future rewards (improved health), and studies suggest that individuals from
disadvantaged backgrounds have even greater bias for the present (perhaps due to life demands, stress, and
cognitive load). Addressing these two processes (lack of reinforcement and bias for the present) in obesity
treatment may uniquely meet the needs of this high-risk, underserved population and result in weight loss
success. The proposed study will test the efficacy of a mHealth behavioral economics weight loss intervention
that addresses lack of reinforcement and bias for the present. Lack of reinforcement will be addressed with
small monetary reinforcers delivered at the beginning of treatment. Reinforcers will taper during the initial
treatment period and eventually end. As reinforcers taper, participants will be trained in Episodic Future
Thinking, which has been shown to reduce bias for the present and may improve longer-term weight loss
outcomes. This two-pronged, phased approach that first addresses lack of reinforcement and then bias for the
present is essential. Providing reinforcement immediately at treatment start is necessary to engage participants
straightaway. Then, as participants are developing success experiences with weight loss, which naturally
provides its own reinforcement (improved mood, health, appearance), reinforcers will taper. During this time,
EFT training will begin. This novel behavioral economics mHealth intervention will be compared to a mHealth
only intervention. The two interventions will be delivered primarily via a mobile platform, include treatment
material tailored to this population, and be matched for contact. Thus, the only way the two interventions will
differ is in the inclusion of behavioral economics strategies in BE mHealth. Our primary hypothesis is that the
behavioral economics intervention will yield significantly better weight losses at month 12 (treatment end).
Mediators (food reinforcement, bias for the present), moderators (stress, resilience, obesogenic environment),
and cost-effectiveness will also be explored. If effective, this mHealth behavioral economics intervention would
be a new and transformative intervention approach that significantly improves obesity treatment outcomes in a
high-risk, underserved population.

Public health relevance
Adults from economically disadvantaged backgrounds experience alarming rates of obesity and associated health ailments (e.g., diabetes, cardiovascular disease). To date, there are surprisingly few effective interventions for treating obesity in this vulnerable population. This study will be the first to test a new behavioral economics weight loss intervention designed to uniquely meet the needs of economically disadvantaged adults and, therefore, produce clinically meaningful weight losses in this high-risk, underserved group.